"Natural" and "Organic" cigarette descriptors: association with expectancies, subjective effects, topography, and biomarkers of exposure among daily smokers

PROJECT ABSTRACT
Consumers believe that cigarettes with “organic,” “natural,” or similar descriptors are significantly more appealing,
healthier, or less harmful than cigarettes without these descriptors. Nationwide, over 45% of US smokers believe that
organic tobacco products are less harmful than conventional tobacco products. These misperceptions are even more
pronounced among smokers of Natural American Spirit (NAS) cigarettes, who are 22 times more likely than other
smokers to believe that their brand might be less harmful. There is some evidence that these misleading descriptors affect
potential and current consumers’ smoking behavior, but results are based on self-report. The state of the research does not
tell us how smokers interpret the subjective effects of using a “natural” or “organic” tobacco product, nor do we know if
smokers’ interpretation of their subjective experience affects their actual smoking behavior and subsequent biological
exposures. Guided by response expectancy theory, the purpose of this study is to examine the relationship between
“natural” or “organic” descriptors and health risk expectancies, subjective effects, topography, and resulting biological
exposures. Prior experimental research is limited to online brief exposure studies examining changes in health risk
expectancies and intentions and has not included NAS smokers, who may have preexisting beliefs about “natural” or
“organic” cigarettes that lead to more extreme favorable ratings of “natural” or “organic” cigarettes and more extreme
negative ratings of conventional cigarettes than other smokers. The proposed research will examine how expectancies
regarding “natural” or “organic” descriptors affect subjective effects (e.g., taste), topography (e.g., total puff volume),
and acute exposures (e.g., salivary aldehyde concentrations), linking descriptors with smoking behavior and biomarkers
of exposure among daily smokers of NAS and non-NAS cigarettes. To accomplish these aims, we will enroll 250 adult
daily cigarette smokers of NAS or non-NAS brands (125 in each group) in a within-subjects human laboratory study
manipulating four expectancy conditions (own brand comparator, “natural” advertising, “organic” advertising,
“conventional” advertising). Given NAS smokers’ likely preexisting beliefs about natural/organic tobacco products, we
will examine moderation by NAS preference in each hypothesis. Given women’s more favorable beliefs about organic
products and preliminary data from our team, we will also examine moderation by gender in each hypothesis. This work
addresses the FDA Center for Tobacco Products’ (CTP) goal to understand how changes in tobacco product
characteristics (i.e., descriptors) are associated with knowledge, attitudes, and behaviors. Understanding how
descriptors affect not only perceptions but also the subjective interpretation of using a cigarette is important as FDA CTP
moves forward with regulating not just the packaging, but also the design of tobacco products. These descriptors may
affect consumers’ interpretation of the subjective effects of smoking, leading to unexpected responses to regulatory
actions meant to reduce the abuse liability or appeal of a product.

Public health relevance
NARRATIVE Smokers believe that cigarettes with the “natural” or “organic” descriptors are less harmful than cigarettes without these descriptors, but we do not know if these beliefs are associated with how smokers interpret the experience of smoking a “natural” or “organic” cigarette, nor whether these beliefs are predictive of changes in smoking behavior or biological exposures. The primary goal of this study is to examine the relationship between exposure to “natural” or “organic” descriptors in cigarette advertising and smoking health risk expectancies, subjective effects, topography, and biological exposures. To accomplish this goal, we will enroll 250 adult daily cigarette smokers of Natural American Spirit (NAS) or non-NAS brands (125 in each group) in a within-subjects human laboratory study manipulating four expectancy conditions (own brand comparator, “natural” advertising, “organic” advertising, “conventional” advertising).